Transforming prostate cancer diagnosis: Feasibility testing of a novel system for integrated endorectal MRI and in-bore biopsy

PROJECT ABSTRACT
The development of the novel OmnEcoil system aligns with the NCI’s mission to help people live longer,
healthier lives by providing a faster, more efficient, and more accurate diagnostic test for the estimated 1.4
million men who develop prostate cancer each year. The OmnEcoil system consists of a disposable 20 cm
long endorectal coil and multichannel needle guide with a reusable clamp stand, embedded electronics, and
baseplate. This dynamic, innovative system can work with any standard MRI scanner, and can be used by
radiologists or urologists to perform endorectal MRI and in-bore MRI targeted biopsy of the prostate as a single
procedure. The goal of this STTR project is to take the system from the current tested laboratory prototype
through a feasibility study. The hypothesis that OmnEcoil will allow endorectal MRI and in-bore MRI targeted
biopsy of the prostate in one procedure, with comparable performance to single channel in-bore MRI-targeted
biopsy will be tested via the following aims: 1) confirm that the OmnEcoil system allows for endorectal imaging
and in-bore targeted biopsy; and 2) investigate the cancer detection rate for the OmnEcoil system. The
investigators will recruit 30 men with a suspicious target on MRI (PI-RADS score of 4 or 5) but no significant
cancer (prior TRUS biopsy negative or Gleason score 6 cancer only) to undergo endorectal MRI with MRI-
guided biopsy using the OmnEcoil system in an IRB and IDE approved study at our partner research
institution, Oregon Health and Science University (OHSU). Success will be defined as the acquisition of
diagnostic tissue samples, as determined by pathological review establishing if the samples are adequate or
inadequate for diagnosis. For cancer detection, investigators will measure the percentage of cancer containing
biopsies of suspicious targets. Results are anticipated to show the OmnEcoil system allows for combined
imaging and biopsy of suspected cancer sites in the prostate with comparable performance to single-channel
in-bore biopsy, the best currently available approach. These results would provide sufficient evidence of clinical
feasibility to justify continued product development as well as a Phase II single-arm multicenter pivotal trial of
150 subjects to demonstrate clinical effectiveness. The commercial opportunity is promising with a submarket
of 12,500 repeat biopsy procedures per year. At a price of $1000 per disposable unit, this yields a Serviceable
Obtainable Market in the U.S. of $12.5M and an annual global market as $4B. Initial customers for the
OmnEcoil system will be radiologists at U.S. academic centers, working collaboratively with their institutional
urology colleagues.

Public health relevance
PROJECT NARRATIVE This STTR project will investigate whether the OmnEcoil system can image and reliably biopsy cancer in one accurate and efficient procedure. The standard diagnostic test of transrectal ultrasound-guided (TRUS) systematic biopsy and the newer tests of fusion or in-bore MRI-targeted biopsy are inaccurate, inefficient, and risky with TRUS biopsy, for example, missing 32-49% of clinically important cancers. The OmnEcoil system aims to transform prostate cancer diagnosis, providing a faster, more efficient, and safer diagnostic test for the 1.4 million men who develop prostate cancer every year by enabling combined endorectal MRI and in-bore MRI-targeted biopsy as a single-visit procedure.